Biochemistry, Cellular and Molecular Biology Program: JHU BioGREAT (Biomedical Graduate REsiliency & Adaptability Training)

Project Summary: The Biochemistry, Cellular and Molecular Biology (BCMB) Graduate Program at Johns Hopkins
University is dedicated to training the ‘whole scientist’ and has evolved over the years to include a variety of training
opportunities and institutional resources that foster both scientific independence and professional growth. Each BCMB
student is now required to participate in a 3-part workshop series where they learn how to implement strategies and apply
tools to maintain a productive and healthy work/life balance, as well as to manage time commitments and set priorities
related to research and professional development. However, given the rise of mental health issues in biomedical graduate
students, especially those from underrepresented backgrounds, that were amplified during the COVID-19 pandemic, there
needs to be supplementary support to help biomedical graduate students identify additional tools and strategies to
promote their well-being. The goal of this supplement to the BCMB T32 training program is (1) to establish new training
material to expand on the targeted and longitudinal support and resilience training of BCMB graduate students and (2) to
make the training material available to other graduate programs. Students who complete this new material will be able to
(i) reframe potential setbacks at each program milestone into learning experiences to cultivate resilience and reduce
imposter syndrome, (ii) improve skills supporting self-advocacy in order to communicate personal and professional needs
within the laboratory and department, while navigating power dynamics as a trainee, and (iii) utilize a backwards design
approach to effectively prioritize research and career needs, as well as mitigate conflict when nearing degree completion.
Additionally, this supplement will allow us to package all the material together into a complete resiliency curriculum called
JHU BioGREAT (Biomedical Graduate REsiliency & Adaptability Training). JHU BioGREAT will incorporate best practices
in pedagogy to support a diverse student population, including combining asynchronous teaching material with in-person
workshops using appropriate and accessible active-learning modules. We will host ‘train-the-trainer’ workshops to scale
this resource so it can be adapted and utilized by graduate programs within and outside of JHU to support student
success and promote resiliency throughout the doctoral training process.

Public health relevance
Project Narrative: There is a critical need to further support biomedical graduate student mental health and resiliency challenges given the rigors of graduate training. This supplement will establish a new training curriculum to help biomedical graduate students in the Biochemistry, Cellular and Molecular Biology Graduate Program at Johns Hopkins University identify new tools to manage time, self-advocate, learn from failure, and share other best practices to support their well-being. This curriculum will be developed for a diverse student population with inclusive practices that are scalable so that the entire curriculum can be widely shared across Johns Hopkins and with other institutes and programs.